Elucidating the structural heterogeneity of differentially modified protein systems by tandem-ion mobility spectrometry / mass spectrometry methods.

The precise mechanisms through which post-translational modifications modulate protein function are not clear
nor is it understood how they are implicated in human diseases at the molecular level. The objective of this
proposal is to develop a method that reveals how variations in sequence and post-translational modifications
modulate the structural heterogeneity of proteins. Guided by our strong preliminary data, we will obtain the
objective of this proposal by pursuing the following specific aims: 1) To enable structure-elucidation of
differentially modified proteins by ion mobility spectrometry / mass spectrometry; and 2) To characterize the
structural heterogeneity of differentially modified proteins by tandem-trapped ion mobility spectrometry / mass
spectrometry. In the first Aim, we will develop a method that determines structures for differentially modified
proteins and their assemblies, in particular for phosphorylated and glycosylated species. In the second Aim, we
will develop an approach that reveals how protein structure depends on amino acid sequence and post-
translational modifications. The research proposed in this application is innovative because it substantially
advances from the status quo through unique computational and experimental methods that were recently
developed in our lab, namely the Structure Relaxation Approximation and tandem-trapped ion mobility
spectrometry/mass spectrometry methods. This contribution is significant because it is the first step towards a
general analytical method that is expected to provide a molecular-level understanding of how changes in amino
acid sequence and post-translational modifications are implicated in disease mechanisms. Ultimately, the results
of the proposed work can be expected to significantly benefit a number of research areas relevant to the mission
of the NIH, including the development of a vaccine against HIV/AIDS.

Public health relevance
The proposed research is relevant to public health because a method that is able to link the structural heterogeneity of protein systems to the presence of variations in amino acid sequence and post- translational modifications is ultimately expected to lead to new approaches to preventive and therapeutic purposes, in particular to the development of a vaccine against HIV/AIDS. The proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that enhances human health.